OADDL Testing Support for CVM Vet-LIRN

OADDL Testing Support for CVM Vet-LIRN (PI-Akhilesh Ramachandran) Abstract: The focus of this proposal is to seek funding for Oklahoma Animal Disease Diagnostic Laboratory (OADDL to support critical CVM Vet-LIRN (Veterinary Laboratory Investigation and Response Network) surveillance and diagnosticprograms by providing testing of clinical samples, animal food/feed/drug samples, environmental samples related to animal food/feed/drug and animal diagnostic necropsy services. OADDL is a full service diagnostic laboratory founded in 1976 and has maintained continuous accreditation with the American Association of Veterinary Laboratory Diagnosticians (AAVLD) since 1978. OADDL has the necessary expertise, infrastructure and cutting edge technology to provide tremendous benefit to CVM Vet-LIRN critical projects.

Public health relevance
OADDL Testing Support for CVM Vet-LIRN (PI-Akhilesh Ramachandran) Project Narrative: The animal industry is a major contributor to sustaining a nation's economy. With the recent outbreaks of food borne pathogens and zoonotic diseases it has become evident that healthy animals are a critical component of a healthy society. In the proposed cooperative agreement Oklahoma Animal Disease Diagnostic Laboratory (OADDL) offers its expertise and services to participate in critical disease testing and surveillance projects initiated by the Food and Drug Administration (FDA), Center for Veterinary Medicine (CVM) Office of Research Veterinary Laboratory Investigation and Response Network (Vet- LIRN).